High Frequency Dielectric Sensing Cardiac Radio Frequency Ablation Monitoring and Lesion Assessment System

Atrial fibrillation (AF) affects over 6 million individuals in the USA and is a significant cause of morbidity
and mortality. Percutaneous catheter Radio Frequency Ablation (RFA) treatment of AF is the standard of
care for treatment of AF. However, current procedures have a ~50% recurrence rate, due to incomplete
ablations and carry a ~4% risk of complications, due to excessive RF energy deposition. There is an urgent
unmet clinical need to improve the safety and efficacy of cardiac RFA procedures.
To address this clinical need; we are developing an intraoperative High Frequency Dielectric Sensing
Lesion Assessment system (HFDS-LAS). Our solution involves; designing the ablation electrode of an RFA
catheter as a “miniature radar” to monitor the electrical properties of the tissue adjacent to the antenna-
electrode. The system comprises; a) steerable ablation catheter with an integrated antenna-sensor ablation
electrode, b) vector network analyzer to measure tissue dielectric properties in a frequency range of 10 MHz
to 4 GHz, c) RF filter hardware to filter ablation (KHz) and measurement (MHz-GHz) frequencies and d)
intuitive graphic user interface which displays procedure parameters, state of lesion formation and warns of
adverse events at high speed and accuracy.
During Phase 1 SBIR project, we prototyped a first-of-its-kind Cardiac HFDS-LAS comprising a 9.5Fr
RFA catheter with an antenna-sensor electrode, band selective filter hardware and a prototype Guidance
User Interface (GUI). In bench and animal (n=5) testing, we definitively demonstrated feasibility of
intraoperatively monitoring cardiac RFA procedures to accurately: confirm and quantify electrode-tissue
electrical contact; characterize tissue; confirm and assess lesion formation/extent of ablation; and predict
micro-bubbles and steam-pops to titrate RF power to safely and efficaciously deliver atrial lesions. The
system is compatible with all EP cathlab equipment e.g. cardiac mapping systems, etc., with no changes to
cardiac RFA procedural workflow.
During Phase 2 of the project, we will optimize and test to finalize design of a clinical grade HFDS-LAS,
comprising 8.5Fr catheter with omnidirectional antenna-sensor electrode, high fidelity filter hardware and a
GUI displaying tissue type, lesion formation and critical procedure parameters. The system will undergo
verification and performance testing in vitro and validation testing in animals to definitively quantify system
performance; and enable submit a pre submission and a submission to the FDA for IDE clearance towards
a safety and efficacy clinical trial.

Public health relevance
Atrial fibrillation is a significant cause of morbidity and mortality; percutaneous cardiac catheter radio frequency ablation is used to treat atrial fibrillation, but it is limited by high recurrence rate due to inability of intraoperatively assess lesion formation and distinguish ablated from non-ablated tissue. We propose to develop and commercialize a novel high frequency dielectric sensing (HFDS) ablation monitoring and lesion assessment system which will enable intraoperatively monitor procedure parameters, distinguish tissue types, confirm and assess lesion formation and enable titrate RF power to prevent collateral injury. The HFDS system has the potential to significantly improve RFA outcomes by reducing recurrence rates and preventing collateral injury, with a consequent impact on associated health-care costs and quality of life for patients.